CORE--PROTEIN SYMTHESIS

DESCRIPTION: (taken from the application). The continued operation of the previously funded Protein Synthesis Core is proposed. This facility will provide designed experimental material for the work detailed in Projects 1, 2, 2I and V. The core consists of an Applied Biosystems Model 433A solid-phase peptide synthesizer, a Beckman System Gold HPLC instrument, and a proposed UV/Vis spectrometer. Salary is requested for a dedicated Research Specialist who will maintain and operate the core.